Establishing smoke-free homes with families involved in child protective services: An effectiveness-implementation trial of an integrated program

Project Abstract
Child exposure to secondhand smoke (SHS) is linked to multiple forms of cancer throughout the
lifespan. Young children living in low-socioeconomic status households are at increased risk for
SHS exposure. Families involved with the child protection system as the result of substantiated
child maltreatment are an especially high-risk group for SHS, as these families are often living in
poverty and report high daily smoking rates. Importantly, child maltreatment victimization also
increases risk of cancer and premature death from cancer, independent of parent smoking
behavior. Identifying ways to broadly disseminate effective SHS prevention programs to these
high-risk families is an important strategy for reducing cancer disparities. We propose an
effectiveness-implementation hybrid trial type 1 to examine the impact of integrating two
evidence-based programs, Some Things are Better Outside (SHS prevention program) and
SafeCare® (Child Maltreatment Prevention Program), on establishing a smoke-free home and
on implementation process outcomes. Aim 1 focuses on the refinement of the standardized
integration (systematic braiding) of the two programs into “Smoke-Free SafeCare (SFSC).” Aims
2 and 3 focus on the hybrid trial. Fifty certified SafeCare Providers will be recruited and
randomly assigned to deliver either SFSC or Standard SafeCare. Providers will each serve ten
research families (N = 500) who meet the inclusion criteria (Mother or another person residing in
the home smokes at home). The primary outcome, smoke-free home status, will be measured
via self-report at 4-timepoints (baseline, 8-weeks, 20-weeks, and 1-year), and validated via air
nicotine monitor at 8 weeks and 1-year (Aim 2). Process measures will be collected to examine
how the braided intervention impacts provider fidelity, delivery time and costs, and other
process measures (Aim 3). If effective, SFSC can be efficiently disseminated for widespread
adoption by the National SafeCare Training and Research Center to the over 100 accredited
SafeCare agencies across the United States and worldwide that serve parents involved with
child protection services, reducing cancer risk and disparities for a high-risk population.

Public health relevance
Project Narrative Evidence-based interventions to create smoke-free homes can reduce secondhand smoke (SHS) exposure among young children and thus decrease lifetime risk of cancer. The purpose of this project is to integrate two effective prevention programs, one focused on SHS and another focused on child maltreatment that is widely disseminated to families with young children involved with the child protection system (a high-risk group for SHS). A Hybrid Trial 1 of this integrated intervention, “Smoke-Free SafeCare,” will aid in identifying ways to disseminate effective SHS interventions to high-risk groups, an important strategy for targeting tobacco- related cancer disparities.